ACTG 384, PROTEASE &NON NUCLEOSIDE REVERSE TRANSCRIPTASE INHIBITOR FOR HIV

This multicenter trial is evaluating three treatment regimens to block virus replication and prevent immunologic damage in HIV infected subjects.